Dynamics of HIV Core Interactions

ABSTRACT, PROJECT 1
The overarching goals of the proposed studies are to i) elucidate dynamic, multifaceted interplay between
HIV-1 and host cell that regulates infection and ii) define the virus-host interactions as therapeutic targets.
The post-fusion journey of HIV-1 across the cytoplasm and via nuclear pore complex (NPC) is regulated by
dynamic interactions of the conically shaped virus capsid shell with variety host proteins that either aid
(dependency factors) or inhibit (restriction factors) infection. However, full identity and definitions of
mechanisms of action of the cellular binding partners of HIV-1 capsid remain largely unknown. Furthermore,
it is not clear how HIV-1 has evolved so that its capsid shell can bind selectively to diverse and seemingly
unrelated regulatory host proteins that dictate the outcome of infection. In Aim 1, we will discover and
characterize novel, dynamic interactions between HIV-1 capsid and host cell during virus ingress.
Specifically, our efforts will focus on uncovering previously unrecognized, dynamic networks of cellular
proteins that regulate HIV-1’s journey across the cytoplasm and through the NPC. Furthermore, we will
elucidate structural determinants for selective and avid binding of these proteins to HIV-1 capsid. The
hydrophobic capsid pocket, which engages several HIV-1 host dependency factors, has been successfully
targeted by small molecule inhibitors. However, a relatively low barrier to resistance to current capsid
targeting antivirals is a serious concern. In Aim 2, we will characterize interactions of existing and novel small
molecule inhibitors with distinct sites on HIV-1 capsid. Specifically, we will define how known HIV-1 capsid
inhibitors influence a dynamic structure of the conical HIV-1 capsid shell. Moreover, we will discover novel
small molecules that bind at distinct sites on HIV-1 capsid and retain activity against viral variants resistant
to current inhibitors. To accomplish above two aims we have assembled a highly collaborative B-HIVE team
with complementary, multidisciplinary expertise in cryo-ET, cryo-EM, X-ray crystallography, HDX-MS, native
MS, molecular modeling, live cell microscopy, virology, molecular biology, biochemistry, and medicinal
chemistry. Our research will generate unprecedented insight into virus-host interactions that regulate HIV-
1’s journey during the virus ingress and define these interactions as the principal therapeutic target.
Moreover, our structural and mechanistic characterization of multiple, distinct small molecule binding sites
on the conical capsid surface will provide powerful means for ongoing efforts in pharmaceutical industry to
rationally develop next generation of long-acting capsid inhibitors with enhanced barrier to resistance to
transform care of the people living with HIV-1.